Trauma-informed data science to prevent intimate partner violence among pregnant and postpartum women

ABSTRACT
We aim to develop a short course titled “Trauma-Informed Data Science and Digital Health Technologies to
Prevent Intimate Partner Violence among Pregnant/Postpartum Women” that will train a new generation of
researchers in specialized research techniques, such as big data analytics and digital health technologies, to
measure or predict intimate partner violence (IPV) more accurately and develop accessible, trauma-informed
digital tools to support IPV survivors of underrepresented pregnant/postpartum women. We propose this
course as an effort to mitigate the existing limitations in measuring, screening, and intervening with IPV to
prevent IPV and reach out to more vulnerable survivors for support. There are multiple barriers (e.g., stigma
and shame) to collecting reliable data from survivors, resulting in small samples without enough statistical
power and, thereby, discouraging the analysis of subgroups of underrepresented women with intersecting
identities. Additionally, the existing interventions/services lack scalability because most services are responsive
vs. proactive and offered in person, reducing the accessibility to these resources among hard-to-reach
survivors. Ethical use of data science and digital health technologies will be innovative research tools for
targeted yet wide-reach preventive strategies for survivors of underrepresented pregnant/postpartum women.
The ethical use indicates factoring in the unintended consequences of employing big data analytics and digital
health technologies and applying trauma-informed principles in the research processes and products. Our
specific aims are (i) training researchers in big data analytics to work with complex data containing IPV,
pregnancy-related, and social determinants of health variables from various sources; (ii) teaching them the
best practices to develop, deploy, and disseminate digital tools (e.g., mobile app and game) that are trauma-
informed; (iii) instructing them conducting ethical research acknowledging the importance of digital security and
privacy in working with IPV survivors. This 6-month education program will welcome trainees with diverse
backgrounds from across the country for hybrid online learning (combination of asynchronous and
synchronous) and intensive, hands-on curriculum to maximize the effectiveness of the training, wide reach to
target groups, and readily disseminate the course. Year 2 will repeat the Year 1 curriculum with its refinement
based on the trainees’ feedback. The program will also involve working groups, in which trainees will generate
research ideas and apply the knowledge and skills obtained from the course for manuscripts or grants, as well
as networking opportunities for mentorship and collaboration. This program will be held at the Emory University
School of Nursing, leveraging its rich institutional and human resources, including the current T32 program
focusing on women’s health and data science. By bringing together training, research, and networking, we will
create a long-lasting community of scholars who can engage in data-driven interdisciplinary research for years
to come to prevent IPV-associated maternal morbidity and mortality.

Public health relevance
PROJECT NARRATIVE This program will equip researchers with knowledge and skills of big data analytics and digital health technologies for more accurate measurement of intimate partner violence (IPV) and accessible, trauma- informed interventions with IPV survivors of underrepresented pregnant/postpartum women to reduce maternal morbidity and mortality.